Assessing State Emotions and Acute Alcohol Intoxication on Sexual Assault Risk Perception

Project Summary
One in five undergraduate women experience sexual assault (SA) during their college career, most commonly
under the influence of acute alcohol intoxication. One critical mechanism through which intoxication increases
risk for SA is a reduced ability to perceive SA risk cues due, in part, to the diminished attentional capacity that
occurs during intoxication. While laboratory studies have consistently observed greater reductions in SA risk
perception among intoxicated versus non-intoxicated women, the potential influence of state emotion on SA
risk perception during acute alcohol intoxication remains unexplored. This is a critical gap given theoretical
evidence to suggest that SA risk perception may be influenced by both negative and positive state emotions.
Accordingly, the proposed study will assess the roles of negative and positive emotion states and acute alcohol
intoxication on SA risk perception (Aim 1) as well as identify subjective (e.g., self-report) and objective (e.g.,
electrodermal response [EDA], heart rate variability [HRV]) indices of emotion states that underlie changes in
SA risk perception during acute alcohol intoxication (Aim 2). In a single experimental session, participants (i.e.,
undergraduate women aged 21 and older who use alcohol) will be randomly assigned to one of two alcohol
conditions (i.e., alcohol or no-alcohol) and one of three idiographic emotion induction conditions (i.e., positive,
negative, or neutral) prior to completing a SA risk perception task. Participants assigned to the acute alcohol
intoxication condition will be administered alcohol to achieve a target BAC of .08 (i.e., a dose of alcohol
equivalent to approximately four standard alcohol drinks). Positive, negative, or neutral emotion state will be
achieved using a validated idiographic emotion induction task. SA risk perception will be measured using a
hypothetical SA vignette designed to assess instances of discomfort and decision of when to leave the
hypothetical scenario. Subjective intensity and regulation of state emotion will be assessed via self-report
measures administered pre- and post- emotion induction as well as post-SA risk perception task. EDA and
HRV will capture objective arousal and regulation of state emotion, respectively, and will be measured
continuously during the experimental session with the BIOPAC MP36. This study is the first to utilize a
laboratory-based, multi-method approach to explicate the roles of state emotion and acute alcohol intoxication
on SA risk perception. In alignment with the NIAAA strategic plan, findings will help develop and improve
strategies to reduce and prevent alcohol-related harm, such as SA among undergraduate women. Additionally,
the proposed project would provide the Applicant with training that will inform her future research on the
intersection of SA and alcohol, including via the development of skills necessary for conducting sophisticated
experimental paradigms relevant to the study of state emotions (e.g., use of biomarkers), acute effects of
alcohol (e.g., alcohol administration), and SA risk perception (e.g., vignette methodology).
2

Public health relevance
Project Narrative Undergraduate women are at increased risk for sexual assault (SA) during acute alcohol intoxication due, in part, to the effects of acute alcohol intoxication on the ability to perceive SA risk cues. Given the relevance of emotions to decision-making and assessment of risk, a critical next step in this line of research is to investigate whether state emotions influence SA risk perception during acute alcohol intoxication. The proposed study will help inform the development and refinement of strategies to prevent alcohol-involved SA among undergraduate women by using an innovative, multi-method experimental paradigm to examine the influence of both negative and positive emotion states on SA risk perception during acute alcohol intoxication.